Translating Hyperpolarized 13C MRI as a Novel Tool to Predict Treatment Response in Pancreatic Cancer

Project Summary/Abstract
This project is designed to develop a new approach to monitor and predict treatment response in patients with
pancreatic ductal adenocarcinoma (PDA) using hyperpolarized (HP) 13C pyruvate MR molecular imaging. PDA
is among the deadliest cancers and is anticipated to become the 2nd leading cause of cancer-related death in the
US by 2030. Most PDA patients present with nonresectable disease where systemic therapy is the only life-
prolonging treatment. In the minority of patients (~30%) who present with localized, potentially resectable disease,
neoadjuvant therapy (NAT) followed by surgery is an emerging approach to improve patient survival but is only
beneficial if the selected NAT is effective. For all PDA patients, effective systemic therapy is the single most
important factor influencing their survival. However, current response assessment tools, including MRI, CT, and
the serum tumor marker CA19-9 provide poor early assessment of response in patients with rapidly lethal
advanced PDA, and are suboptimal for selecting patients most likely to benefit from a highly morbid surgery after
NAT. Therefore, there is a critical unmet need for more timely and accurate indicators of therapy response in
PDA to 1) promptly discontinue ineffective treatments and switch to alternative treatments with potentially better
efficacy, and 2) better guide clinical decisions regarding surgery following NAT. Metabolic reprogramming
towards increased glycolysis is a hallmark of PDA. In particular, the over-expression of lactate dehydrogenase
A and monocarboxylate transporter 1 and 4 results in high levels of pyruvate conversion to lactate, which plays
a central role in PDA progression and therapy resistance. Such reprogrammed glycolytic metabolism can be
noninvasively interrogated using HP 13C pyruvate MRI, an emerging molecular imaging method that provides
dynamic and pathway-specific metabolic information not available with current imaging methods including
[18F]fluorodeoxyglucose positron emission tomography (FDG-PET). Our preliminary patient studies demonstrate
reprogrammed glycolytic metabolism in PDA using HP 13C pyruvate MRI, with increased conversion to lactate
and reduced conversion to alanine in tumors compared to normal pancreas. Our preliminary results also suggest
that early metabolic changes measured by HP 13C pyruvate MRI can predict tumor response to therapy. Building
on these exciting results, we propose to investigate for the first time the value of HP 13C pyruvate MRI for therapy
response monitoring in PDA patients. In Aim 1, we will develop and refine HP 13C pyruvate MRI acquisition, post-
processing, and analysis strategies optimized for PDA metabolic evaluation. In Aim 2, we will monitor early
therapy response using this imaging approach in patients with advanced/nonresectable PDA. In Aim 3, we will
determine whether HP 13C pyruvate MRI can predict response to NAT through correlation with pathologic
response in patients with resected PDA. Successful completion of this project will provide the first data on HP
13C pyruvate metabolism of PDA in response to therapy, with the overarching goal of better guiding clinical
decision making to improve survival for patients with this deadly disease.

Public health relevance
Project Narrative The proposed project will develop a new approach to monitor and predict treatment response in patients with pancreatic ductal adenocarcinoma using hyperpolarized 13C pyruvate MR molecular imaging. The data from this first study will inform future investigations incorporating metabolic imaging biomarkers for defining clinically relevant thresholds, enable timely therapy switch in non-responders, and guide high-stake decisions about the benefit of a highly morbid surgery, with the overarching goal of better guiding treatment decisions to improve survival of patients with this deadly disease.